Community Engagement Core

COMMUNITY ENGAGEMENT CORE: PROJECT SUMMARY
The Community Engagement Core (CEC) will translate ShARP Center research findings to increase
environmental health awareness on water contamination and health risks from Superfund hazardous substances
to mitigate PFAS contamination. For Aim 1, the CEC will facilitate communication between the ShARP Center
and local, regional, and national audiences on PFAS exposures and health risks. To achieve this aim, the CEC
will develop collaborations with local leaders to help inform the ShARP Center of local concerns about ongoing
and emerging environmental health issues. For Aim 2, the CEC will utilize education as prevention tools for
responding to local concerns about PFAS contamination. To achieve this aim, the CEC will: (a) partner with local
organizations and healthcare workers to conduct workshops and trainings to increase awareness about PFAS
and other Superfund hazardous substances and their health effects; and (b) work with local leaders to prioritize
concerns and respond by providing scientific expertise to increase environmental health literacy, including
providing skill-based training of healthcare workers and individual ShARP investigator consultations with local
partners. For Aim 3, the CEC will integrate community collaborations for science dissemination to local,
statewide, and national audiences. CEC personnel will collect local information and integrate this information to
influence ShARP Center projects’ methods, data generation, analysis, and dissemination of research findings.
The CEC will also utilize innovative communication methods, tailoring print and web-based materials and
resources for intended audiences, creating easy-to-understand materials for ShARP research findings. For Aim
4, the CEC will co-develop potential prevention efforts utilizing ShARP Center research findings in combination
with local collaborations. The CEC will facilitate ShARP Center investigators and local partners to utilize research
findings and local information to collaboratively identify and design recommendations to address PFAS
contamination. Collectively, the CEC will ensure collaboration across all ShARP Center projects and cores by
informing all Center investigators of local concerns to strengthen scientific dissemination and prioritize emerging
research needs.

Public health relevance
COMMUNITY ENGAGEMENT CORE: PROJECT NARRATIVE The Community Engagement Core (CEC) supports the mission of the Southern California Research and Training Program for PFAS Assessment, Remediation, and Prevention (ShARP) by increasing awareness of PFAS contamination and health risks from Superfund hazardous substances. It will foster communication with local and national stakeholders, deliver educational outreach, and support dissemination strategies. These activities will inform ShARP research and promote evidence-based prevention strategies.